Novel cell type-specific epigenetic role of nuclear lncRNAs in 3D heterochromatization and transcriptional repatterning in the MDD brain

Converging evidence suggests that major depressive disorder (MDD) involves maladaptive processes impairing
the ability of individuals to appropriately interface with the environment leading to compromised structural and
synaptic plasticity in the cortico-limbic brain areas. So far, no coherent hypothesis fully explains this
phenomenon. Fine-tuning of transcriptional regulation by gene x environment interaction is central to MDD
etiology. In this regard, long-non-coding RNAs (lncRNAs), a class of regulatory RNAs, are gaining traction for
their role in key brain functions and behavior, including MDD. How lncRNAs participate in MDD pathogenesis is
not clearly understood; however, their potential engagement in epigenomic reprogramming and subsequent fine-
tuning of the transcriptome at the genome-wide level is being considered a paradigm shift in understanding the
refinement of cellular processes. Remarkably, a majority of lncRNAs are selectively expressed in the brain in a
cell and tissue-specific manner. More importantly, lncRNAs have access to chromatin due to their permanent
presence in the nucleus, where they can participate in the programmed arrangement of linear chromatin structure
to conformational compactness, a process pivotal to epigenetic reprogramming. Specifically, nuclear lncRNAs
may cause a facultative progression of a heterochromatin state following a higher-order chromatin structure
formation in 3-dimensional (3D) space, which can initiate genome-wide silencing of transcriptional activity. This
can possibly be achieved through nuclear lncRNA-mediated recruitment of chromatin modifier PRC2 in
conjunction with methyltransferases EZH2 and SUZ12, thereby facilitating the placement of H3K27me3
repressive histone marks on chromatin. Interestingly, both lncRNAs and chromatin conformational changes are
highly sensitive to environmental cues. Using a multitude of innovative approaches, the proposed study seeks
to mechanistically examine nuclear lncRNA regulation of 3D chromatin organization and its functional
significance in MDD. We propose an overarching hypothesis that a dynamic shift in the expression of a unique
pool of nuclear lncRNAs, their interactions with specific RNA binding chromatin modifiers, and consequent
repatterning of global gene expression via a facultative progression of 3D heterochromatin state in a cell type-
specific manner will be central to MDD pathogenesis. To test this, in the prefrontal cortex and hippocampus from
MDD and well-matched controls, we propose to examine: 1) global shift in nuclear lncRNA transcriptome and its
correlatedness within an expression framework in a cell type-specific manner; 2) cell type-specific 3D chromatin
conformation changes mediated via a specific repertoire of nuclear lncRNAs following genome-wide analysis of
higher-order chromatin organization; 3) role of chromatin modifier PRC2 complex and its interaction with nuclear
lncRNAs in reshaping 3D heterochromatin organization; and 4) impact of nuclear lncRNA-mediated 3D
heterochromatinization on global gene expression and consequent functional responses in a cell type-specific
manner. If proven, the study will provide novel avenues to develop lncRNA-based therapeutic interventions.

Public health relevance
Major depression is a debilitating disorder affecting millions of people worldwide with limited success in treatment or remission. Despite a wealth of neurobiological studies over the last few decades, our understanding of the cellular and molecular processes associated with major depression is rudimentary, precluding the development of effective treatments. In this application, we are proposing an innovative line of research to examine the unique role of a class of genes that do not code for protein, named long non-coding RNAs, particularly those residing in the nucleus, for their role in reshaping chromatin in 3-dimensional space with the help of specific epigenetic modifiers in order to epigenetically silence the expression and functions of protein-coding genes that can be used as a novel ‘‘molecular tool’’ to understand the etiopathogenesis of depressive behavior with a high potential to generate new molecular-based therapies to treat this severe mental disorder.